Molecular mechanisms that regulate polarity and spindle orientation in animals

Project Abstract
Animal cells are asymmetric, often containing different proteins at distinct areas of the
membrane. For example, the cells that line our digestive tract are poised to take in nutrients
from one side of the cell and deliver them to the rest of the body at the other side. This proposal
examines the activity of the Par complex, a set of proteins responsible for creating and
maintaining different regions of animal cell membranes. We are also examining how cellular
asymmetries are translated into the complex organization seen in animal tissues and organs.
One mechanism for creating structure within tissues is to control the placement of the cells that
result from a division. This can occur by positioning the mitotic spindle–the apparatus that
separates the chromosomes during division–along a particular axis. We are determining how
certain areas of the cell membrane recruit molecular motors that generate forces to rotate the
spindle into position and construct organized tissues in the process. In general, our work aims to
understand how cells process information to speciﬁcally target polarity and spindle orientation
complexes to the appropriate region of the cell at the right time, activate these complexes once
they're localized, and how the activity of these complexes is translated into complex cellular
functions.
Our goals over the next ﬁve years are to identify the molecular interactions that specify
polarization of the Par complex in asymmetrically dividing neural stem cells and activate the
enzyme activity contained within the complex. In previous work, we determined how the Par
complex polarizes its substrates and we are attempting to use this to “reverse engineer” the
identiﬁcation of new polarized proteins. The premise of this project is that knowledge of new
polarized factors will help us understand how Par polarity is translated into function, such as the
polarized transport found in the epithelial cells in our digestive system.
We are also speciﬁcally interested in one important polarity output: mitotic spindle orientation.
The premise of this project is that animal cells often align their mitotic spindle with the axis of
polarity during division. One reason for doing this is that it controls the position of the resulting
daughter cells, a feature that is important for the construction and maintenance of complex
tissues. Our focus is on a protein that is required to prevent cancer-like over proliferation.

Public health relevance
Narrative Many cells in our body, such as skin cells that provide a physical barrier to the environment, are polarized and loss of polarity is a hallmark of many diseases, including cancer. In this work, we are investigating a set of two proteins, known as the Par complex, that regulate cellular polarities required for proper development and adult physiology. As the loss of polarity is associated with human disease, improving our understanding of the molecules that control this process will contribute to our knowledge of the mechanisms of disease states. We are also investigating how cell polarity is translated into cellular function. Many animal cells divide with a speciﬁc orientation, and in many cases they control division orientation by positioning their mitotic spindle, the cellular machine responsible for separating chromosomes during division. Here again, mistakes in this process can lead to disruptions in normal physiology, such as the highly organized architecture normally found in our tissues and organs.